Investigation of the neurobiological mechanisms underlying estradiol-mediated risk aversion in females

Project Summary:
This application is for an Administrative Supplement for Continuity of Biomedical and Behavioral Research
Among First-Time Recipients of NIH Research Project Grant Awards. Elevated risk taking may be due to chronic
drug exposure and contribute to continued drug use and/or promote relapse. Animal models have been
invaluable in identifying whether such elevated risk taking arises from drug-induced alterations in neural
substrates that govern risk taking in drug-naïve states (i.e., prior to drug exposure). Although there has been
significant progress in answering such questions, we still face a significant barrier in translating these findings to
the clinical setting. Not only is our understanding of the neural substrates of risk taking based on studies using
only males, but prior studies have also primarily focused on how hypersensitivity to reward (as opposed to
hyposensitivity to punishment) promotes elevated risk taking after drug use. Little is known about the neural
substrates underlying risk taking in females, let alone how such substrates are altered after drug exposure. Our
long-term goal is to uncover the biological mechanisms mediating punishment-based risky decision making in
females to identify how these processes become compromised by drug use. To meet this goal, we use a rat
model of risk taking in which females are more risk averse and exhibit greater sensitivity to risk of punishment
than males. In this model, we find that E2 mediates female risk aversion through estrogen receptor (ER)
activation. The basolateral amygdala (BLA) is also necessary for promoting risk averse behavior, and activation
of D2 dopamine receptors (D2R) in the BLA leads to risk aversion in females, but not males. This suggests
differences in BLA function may underlie sex differences in risk taking, which is consistent with greater overall
BLA activity in females than males. Prior work shows female-specific BLA activity and BLA-dependent behavior
are due to E2’s ability to modulate BLA function. Our overarching hypothesis is that female risk aversion
depends on E2’s ability to regulate BLA excitability via modulation of ERs and D2R function and suppression of
interneuron activity. This hypothesis will be tested in 3 aims. Aim 1 will determine the ER mechanisms in the
BLA contributing to E2-dependent female risk aversion using behavioral pharmacology, in vivo electrophysiology
and RNA interference-mediated ER gene reduction. Aim 2 will identify the contribution of E2 modulation of BLA
D2R function to female risk aversion using genetic ablation and optogenetic manipulation of BLA D2R-
expressing neurons. Aim 3 will evaluate the role of BLA interneurons in E2-dependent female risk aversion using
fiber photometry and optogenetics. The information gained from these experiments will be significant because
it will provide the necessary foundation from which we can assess the efficacy of targeting E2-dependent neural
mechanisms to alleviate elevated risk taking associated with substance use. This Administrative Supplement will
offset the reduction in productivity that occurred when the PI gave birth to her first child five weeks prematurely,
resulting in a NICU stay for the newborn and a week-long hospital stay for the PI.
.

Public health relevance
Project Narrative Substance use disorder (SUD) is a costly and debilitating condition closely associated with poor decision making and elevated risk taking. Although significant strides have been made toward identifying the neural mechanisms by which substance use increases risk taking, the majority of this work is based on studies investigating the neural substrates of risk taking in males; consequently, we have an impoverished understanding of the neural substrates underlying risk taking in females, even before drug exposure. To begin to address this significant gap in knowledge, this R01 seeks to elucidate the neurobiological mechanisms underlying hormone-dependent risk taking in females, the findings of which can then inform our understanding of how such mechanisms may be compromised after chronic substance use in females and lead to elevated risk taking.